Chemical Probes of Complement Pathways

Project Summary/Abstract Section
The rise of resistant strains of antibiotic-resistant bacterial pathogens demands new approaches
to combat the infectious diseases they cause. An alternative to standard small-molecule
antibiotics is to co-opt endogenous mechanisms for eliminating microbes, such that they
operate rapidly and efficiently to eliminate the infectious cells. Complement recruitment offers a
means of co-opting these natural defenses, but implementing this approach requires insight into
the molecular mechanisms underlying complement-induced immune responses. The focus of
Aim 1 is to generate a series of multifunctional compounds that bind to the gram-negative
bacteria Pseudomonas aeruginosa through different mechanisms. The utility of these
compounds to effect recruitment and cell killing will be assessed. These studies will provide
insight into the relative efficiencies of the classical and lectin-mediated complement pathways.
In Aim 2, the probes developed in Aim 1 will be evaluated for their ability to promote pathogen
uptake by immune cells and the consequences on immune cell signaling. We anticipate that the
pursuit of these aims will reveal insight into the utility of co-opting complement as a means of
eliminating critical pathogens.
Significance:
The overall objective of this application is to develop new chemical probes to explore the
consequences of different complement recruitment strategies. We anticipate that this knowledge
will ultimately lead to the identification of new strategies for treating infections caused by gram-
negative bacteria.

Public health relevance
Project Narrative Our current antibiotics are losing their effectiveness, so new strategies to treat infections are needed. One immune system mechanism to eliminate infection-causing bacteria is to mark pathogens with proteins that comprise the complement system, which either kills the pathogens directly or recruits immune cells to dispose of them. Unfortunately, some pathogens evade these mechanisms. This project aims to exploit and expedite intrinsic antibacterial mechanisms by generating molecules that are highly effective at bringing complement to the bacterial cell surface.